Lytic viral genes in the pathogenesis of oncogenic gammaherpesviruses

PROJECT SUMMARY
The human gammaherpesvirus (GHV) Kaposi sarcoma-associated herpesvirus (KSHV) establishes lifelong
latency to cause several AIDS-associated malignancies including Kaposi sarcoma (KS) and primary effusion
lymphoma (PEL). Because the virus is predominantly latent in these tumors, the prevailing model for KSHV
transformation is that latency genes are the primary drivers of these viral cancers. However, published case
reports in KS patients together with our preliminary data indicate that lytic gene expression may also be required
for KSHV cancers. Whether lytic replication and reactivation influence tumor development and maintenance has
not been directly tested. Our over-all objective is to test the hypothesis that lytic genes are drivers of GHV
cancers. In this proposal, we will study how lytic gene expression is involved in the two distinct stages of GHV
cancers (development and maintenance) using in vivo models. Specifically, we will inactivate the master
regulators of the GHV lytic transcriptional program, ORF50 and ORF57, to prevent lytic gene expression. In Aim
1, we will test if lytic gene expression and reactivation is required for tumor initiation using conditional knockouts
of ORF50 or ORF57 in the GHV murine gammaherpesvirus 68 (MHV68) in a newly developed B cell
lymphomagenesis mouse model. MHV68 is a natural rodent virus that is genetically related to KSHV and
provides a well-established, extensively studied, and tractable small-animal model for defining basic viral
mechanisms of GHV pathogenesis. In Aim 2, we will test if lytic gene expression is required for the maintenance
of KSHV lymphoma in a PEL xenograft mouse model. Using an inducible RNA-targeting CRISPR/CasRx system,
we will target ORF50 or ORF57 RNA for knockdown in PEL cell lines after implantation in NOD scid gamma
(NSG) mice. In addition, we will perform high-throughput targeting of the KSHV transcriptome using our newly
designed CasRx tiling library in this well-established xenograft model to identify in vivo lytic drivers of PEL
maintenance in an unbiased manner. Together, these complementary Aims will directly address the hypothesis
that lytic gene expression is required for the development (Aim 1) and maintenance (Aim 2) of GHV cancers in
vivo. We anticipate that our work will challenge the current latency-centric paradigm of GHV oncogenesis, and
shed new light on roles for viral genes in pathogenesis.

Public health relevance
PROJECT NARRATIVE Kaposi sarcoma-associated herpesvirus (KSHV) is a gammaherpesvirus that establishes lifelong chronic infections in lymphocytes and other cells, placing the host at risk for several cancers, especially in persons who are immune suppressed or infected with HIV. Defining interactions between KSHV and the host, especially how specific viral proteins and stages of the viral infection cycle influence disease, is important for understanding the processes of disease development and could highlight steps in the process to target therapeutically. The work of this proposal will employ model systems and genetic screens to better define mechanisms used by KSHV to cause disease in an infected host.